Exploring the dynamics of nsp1 and RNA interaction in SARS-CoV with undergraduate researchers

Project Summary
Viral host shutoff proteins selectively hijack cellular machinery to aid viral propagation. In SARS coronaviruses
(SARS-CoV-1 and SARS-CoV-2), nonstructural protein 1 (nsp1) serves as the host shutoff factor by
dampening host gene expression through ribosomal stalling on host mRNAs followed by their cleavage and
decay. However, how nsp1 selectively targets host mRNAs over the viral RNA remains an unsolved puzzle.
The long-term goal of this research is to study the steps of nsp1-mediated host shutoff to clearly understand
how it specifically selects host mRNAs but not capped and polyadenylated viral RNA that resembles host
mRNAs. The rationale for this project is based on the observation that the deletion of stem-loop 1 (SL1) from
the viral RNA leader sequence eliminates its ability to escape host shutoff. A critical factor in differentiating viral
RNA from host mRNA lies in the interaction between nsp1 and SL1. Based on our previously published results
that nsp1 associates with stress granule proteins and disengages G3BP1 protein from the stress granule, we
propose to examine the protein and RNA composition of stress granules to determine if viral RNA is protected
from decay because of its specific localization connected to the interaction between nsp1 and viral RNA. In
Aim 1, we propose to conduct an in-depth study of the interaction between nsp1 and SL1 that will map the
sequence responsible for binding, characterize the proteomic profile of the host proteins bound to SL1, and
analyze the effect of nsp1 on host mRNA translation and stability. In Aim 2, we propose to examine the
disassembly of stress granules in the presence of nsp1 and study its effect on selective cleavage and decay of
host mRNA. This multidisciplinary collaborative research will engage undergraduate students to be trained in a
highly transformative experience with a team of biochemists, computer scientists, and immunologists to
explore a current and relevant topic in biomedical sciences. Overall, our research will connect nsp1’s ability to
bind viral RNA sequence to RNA stability and localization and will allow us to examine the mechanism that
leads to host mRNA cleavage and decay. Finally, this project will identify interactors of nsp1 and pave the way
for designing anti-viral therapeutics.

Public health relevance
Project Narrative Nonstructural protein 1 (nsp1) of SARS coronavirus acts as a host shutoff protein by selectively stalling protein synthesis from host mRNAs and triggering their decay. In both SARS-CoV-1 and SARS-CoV-2, nsp1 remains a puzzling protein for its intrinsically undefined regions and its ability to differentially select the host mRNA for degradation while ensuring the translation of viral RNA. Using a unique combination of biochemical and computational analysis to study the effect of nsp1 on RNA sequence, the proposed research will train undergraduate students to study the mechanism of nsp1-mediated host shutoff, revealing new targets for anti- viral therapy.